Tissue Engineering and Regeneration

ABSTRACT
This proposal is a competing continuation of a T-32 Institutional Training Grant in Tissue Engineering
and Regeneration (DE07057-45). Since its inception, over 140 trainees have completed this Program (92%
completion %), with 82% in a research-intensive or research-related career.
A primary goal of modern dentistry and medicine is to predictably restore tissues and organs that have
been lost due to pathology, trauma, or congenital abnormalities. Recent advances in understanding the
factors, cells and mechanisms regulating tissue function, coupled with new materials science technologies
capable of providing physiological cues to sites of repair and advances in imaging and bioinformatics have
provided the tools required for researchers to focus on designing "tissue engineered products" for therapeutic
use. These efforts require an interdisciplinary approach, with involvement of biomedical scientists, engineers,
and clinical researchers. TEAM (Tissue Engineering at Michigan), a Training Program in tissue engineering
and regeneration, was developed with recognition of the need to train individuals in these various disciplines
and of the need to ensure active exchange of ideas between individuals across disciplines. The goal of our
Program is to provide an interdisciplinary research-intensive training environment to enable a scientifically and
demographically diverse set of individuals to pursue independent research careers in the oral sciences, with a
focus in the area of restoration of dental-oral-craniofacial tissues. This goal is achieved through coursework,
research training, seminars, journal clubs, career development, responsible conduct of research and
intellectual interplay at the intersection of the life sciences, engineering and dentistry. This Training Program
provides intensive training opportunities in both basic biomedical and clinical science, enabling trainees to work
at the interface of clinical and basic science. Our Training Program is comprised of 3 groups of trainees (2 year
appointments each): 1) DDS/Ph.D. (4 slots); 2) Ph.D. (4 slots), and 3) Post-doctoral Fellow (2 slots).
Trainees will be selected based on strong academic records, research potential, recommendation
letters and commitment to a research career focused in oral science, with an emphasis on tissue engineering
and regeneration. Mentors undergo mentor-the-mentor and DEI training and we have developed T32-specific
initiatives to recruit and retain underrepresented individuals. TEAM is a multidisciplinary program that spans
across departmental and school boundaries, providing trainees the flexibility to choose mentors across
departments. TEAM involves 3 schools, Dentistry, Medicine and Engineering, where in addition to core training
elements in tissue engineering, didactic training is provided through the degree-granting departments at these
schools. The University of Michigan recognizes the importance of quality training programs and is committed
to training oral scientists as independent researchers, enabling the development of a diverse and highly
qualified workforce that significantly impacts oral health.

Public health relevance
PROJECT NARRATIVE The goal of this Training Program is to provide an interdisciplinary research-intensive training environment for individuals who wish to pursue careers in the oral sciences, with a focus on the regeneration of dental-oral- craniofacial tissues. DDS/PhD, PhD, and Post-doctoral Fellows will be trained in a comprehensive Program that spans across departmental and school boundaries, providing intensive training opportunities in both basic biomedical and clinical science. Our commitment to training oral scientists as independent researchers and life- long learners will help develop a diverse and highly qualified workforce that significantly impacts oral health.